Connectivity and Function of the Asymmetric Habenulo-Interpeduncular Pathway

ABSTRACT/PROJECT SUMMARY
The habenulo-interpeduncular pathway, a forebrain to midbrain conduction system in the
vertebrate brain, has been implicated in many essential processes, from sleep to fear/anxiety,
pain, learning, motivation, feeding, reproduction, and reward, and in pathological states such
as mood disorders and addiction. Despite its importance and diverse roles, little is known
about the complete repertoire of neuronal subpopulations and precise connectivity between
the bilaterally paired dorsal habenular nuclei (dHb) of the dorsal diencephalon and their major
target, the unpaired interpeduncular nucleus (IPN) of the ventral midbrain. A renewed interest
in this pathway came from its association with nicotine dependence and withdrawal and from
the discovery that, in zebrafish and other vertebrates, the dHb develop with prominent left-right differences in their size, organization, molecular properties and connections to the IPN.
In previous work, we described an asymmetric olfactory projection to a subset of neurons in
the right dHb that helps mediate the response to aversive cues and determined that altering
directional asymmetry of the dHb induces behavioral and physiological changes indicative of
enhanced fear/anxiety. Using state-of-the-art genetic, transgenic, imaging, and behavioral
approaches, we now aim to identify all of the neuronal populations of the Hb-IPN pathway
and further define which groups of neurons are involved in the response to negative cues.
We have also extended our studies to characterize the pre-synaptic input and post-synaptic
targets of this conduction system to gain a more complete understanding of the underlying
neural circuits and their connectivity. The proposed research will shed light on a poorly
understood yet highly conserved neural pathway and also address how differential
processing of information by neurons on the left and right sides of the brain leads to
appropriate behavioral responses.

Public health relevance
PROJECT NARRATIVE A conserved forebrain to midbrain pathway is involved in a plethora of neural functions, including circadian activity, reward, decision making, anxiety and fear, and has been implicated in neurological disorders such as depression, schizophrenia, and addiction. Understanding how this pathway develops the correct connections between its specific neuronal populations, and how these populations differ on the left and right sides of the brain, will help explain its diverse functions.